Research and Engagement for Advancing Chronic pain Healthcare Equity (REACH)

PROJECT SUMMARY/ABSTRACT
This K23 career development award proposal addresses the underutilization of pain psychology, an effective
frontline treatment, among socioeconomically disadvantaged individuals suffering from chronic low back pain
(cLBP). The primary investigator (PI) seeks to bridge this healthcare disparity through a three-fold research
strategy. Aim 1 proposes to investigate the impact of socioeconomic status on pain psychology utilization via a
retrospective cohort analysis. The PI will leverage data from a large, PCORI-funded trial across healthcare
systems in Baltimore, MD, and Salt Lake City, UT. Aim 2 aims to identify the barriers and facilitators to pain
psychology utilization through qualitative interviews with psychologists and patients from a low socioeconomic
stratum. This step will guide the development of the Empowering Pain Psychology Access and Collaboration
(EPPAC) intervention, a patient-centered approach using shared decision-making and motivational
interviewing. Aim 3 pilots the EPPAC intervention among socioeconomically disadvantaged patients with cLBP,
evaluating its acceptability, feasibility, and preliminary efficacy compared to a usual care control group.
This K23 career development award proposal is spearheaded by Dr. Fenan Rassu, an Assistant Professor in
the Department of Physical Medicine and Rehabilitation and a clinical researcher at The Johns Hopkins
University School of Medicine who is determined to address underutilization of evidence-based pain
psychology treatments among socioeconomically disadvantaged individuals with cLBP.
The proposed career development plan includes didactic and research training activities that will substantially
build his skills and expertise. These will include training in health services research, stakeholder engaged
research and qualitative research methods, and implementation science . This training will occur in the rich
training environment of the Johns Hopkins Medical Institutions, including the Bloomberg School of Public
Health. He will receive guidance from his outstanding team of mentors and advisors with expertise in the
methodologies needed for conducting the planned research, and a track record of mentoring and funding. The
award and protected time will allow Dr. Rassu to build an independent NIH-funded research career and
become a leader in improving access and engagement in evidence-based treatments for vulnerable
populations living with pain.

Public health relevance
PROJECT NARRATIVE This K23 project seeks to address the critical gap in the utilization of pain psychology among socioeconomically disadvantaged patients with chronic low back pain (cLBP), a prevalent health issue contributing to health disparities. The project proposes a three-pronged approach: first, to quantify the effect of socioeconomic status on pain psychology utilization; second, to identify barriers to and facilitators of pain psychology services, which will guide the creation of a tailored intervention, the Empowering Pain Psychology Access and Collaboration (EPPAC); and third, to pilot the EPPAC intervention, assessing its acceptability, feasibility, and preliminary efficacy compared to usual care. The successful execution of this project will generate data and expertise, contributing to the PI's long-term goal of promoting equitable and effective use of evidence-based treatments among marginalized pain populations.